Corneal Epithelial-Stromal Interactions During Regeneration and Fibrosis

SUMMARY
Corneal wound healing is a complex process involving corneal epithelial cell proliferation, myofibroblast
generation, and extracellular matrix (ECM) deposition. In corneal wound models, the disruption of the
Bowman's layer that separates the epithelium from stroma is often observed, and this disruption may lead to a
different pathological (fibrotic) state, which we propose can be mediated by the intercellular signaling between
epithelial and stromal cells in part via paracrine factors. TGF-β is a pleiotropic cytokine that exists in three
isoforms (TGF-β1, -β2, and -β3), which exert biological effects through signaling pathways to maintain corneal
integrity and wound healing. Previously, we found that TGF-β1 is involved in corneal fibrotic wound healing by
stimulating myofibroblast differentiation; whereas, TGF-β3 application after corneal wounding reversed and
diminished the fibrotic response in vitro and in vivo, respectively. Despite the functional differences in TGF-β
isoforms, the molecular mechanisms in dampening fibrosis remain poorly understood.
Amid other paracrine factors, extracellular vesicles (EVs) are recognized as mediators for cell-cell
communication. EVs can selectively engulf a part of their parental cell and become enriched in a repertoire of
bioactive cargo (e.g., proteins or lipids), and offset their cargo into recipient cells by ensuing physiological
changes. We have shown that corneal epithelial cell-derived EVs can trigger myofibroblast differentiation and
generate an ECM microenvironment that promotes myofibroblast persistence, which is key for corneal scarring;
however, the bioactive cargo driving this remains unclear. Of disease relevance, keratoconus (KCN) is of
interest because it leads to corneal stromal scarring even without any acute trauma or known underlying
etiology. Pathologically, KCN is similar to our wound-healing models in that the KCN corneas: 1) develop gaps
in Bowman's layer that allow direct contact between epithelium and stroma; 2) have EVs present between
epithelial cells and stroma; and 3) develop myofibroblast differentiation that leads to scarring under the breaks
in Bowman's layer. TGF-β's role in myofibroblast differentiation and ECM remodeling suggests involvement in
KCN's pathogenesis, either in a causative or secondary repair role, leading to structural changes in KCN.
In this proposal, we hypothesize that loading TGF-β3 onto EVs and applying to corneal wounds will drive
healing without scarring by dampening the fibrotic response and preventing the onset of scar formation;
however, TGF-β1-EVs will enhance the scarring in corneal wounds. Through these experiments we will also
determine bioactive cargo from KCN-epithelial cell derived EVs that is contributing to KCN corneal scarring and
disease progression. Relevance to Public Health—Collectively, this proposal will provide key mechanistic
insights into corneal EV biology and their corresponding cargo, as well as identify the bioactive EV cargo that
could be used to predict corneal scarring in KCN patients in the future.

Public health relevance
NARRATIVE Currently, there are no effective non-surgical tools for preventing or treating corneal scarring, which is a complication often observed with advanced keratoconus (KCN) that results in possible blindness and decreased quality of life. Bioactive cargo (e.g., RNA, protein, and lipids) containing extracellular vesicles (EVs) are released by corneal cells to communicate with one another, and those released by the corneal epithelium can trigger myofibroblast differentiation, which may cause scarring and diminish vision if they persist. In this proposal, we will load-EVs with TGF-β1 or -β3 to determine a growth factor that can drive scar-free corneal wound healing, and we will examine the bioactive cargo from KCN-epithelial cell derived EVs that is contributing to KCN corneal scarring and disease progression.